NIDCR DIR Scientific Cores (Combined Technical Research Core)

The NIDCR DIR Scientific Cores provided research support for intramural investigators performing studies on dental, oral and craniofacial diseases.
The Combined Technical Research Core (CTRC)is in it's ninth year of operation. CTRC provides access to state-of-the-art research technologies, scientific expertise, and technical support to enhance the research efforts of all NIDCR DIR investigators. The services that it offers include the following:
1) DNA Sequencing; Provided over 2521 reactions for NIDCR DIR investigator-led research,
2) Flow Cytometry; Trained 16 new investigators and students during this period on the Cytometry analyzers, and 4 investigators on the spectral analyzer- total hours used by investigators was over 2350 hours between the three cytometry analyzers.
3)FACS Cell Sorting; FACS sorted over 1422 hours for 18 investigators.
4)Cell Elutriation, have elutriated tota1 of 113 cell types including Monocytes, PBMC, Platelets, and T-Cells.
5)Histology; Performs tissue processing, sectioning and staining for NIDCR investigators working on almost 200 requests/Tissues.
6)Image- Have trained over 22 new investigator in the use of ScanScopes, AxioScan, Nanozoomer and CeligoS with the usage of over 1534 hours.
CTRC projects increase in demand of its services and resources for the next fiscal year as it has recently trained a few investigators on the Analyzers, Image instruments, and has trained more investigators on the Spectral Analyzer and new Image scanner. Also, of note is FACS sorting demand which has increased by over 350 hours. We have purchased another FACS sorter and installed in May 2022 which has proven to be a great addition to the FACS sorting capabilities within CTRC.